RISK OF LONG-TERM ADVERSE EVENTS IN BREAST CANCER PATIENTS TREATED WITH ADJUVANT CHEMOTHERAPY

Risks of Long-term Adverse Events (e.g., leukemia, congestive heart failure, neuropathy, cognitive dysfunction, infertility) in Breast Cancer Patients Treated with Adjuvant Chemotherapy